Kinases as Therapeutic Targets for Endometriosis

ABSTRACT
The human genome encodes 538 protein kinases, most of which are functionally important and are involved in
the pathogenesis of many diseases. This new R01 is a discovery-based grant focused on the molecular
validation of novel kinases that are upregulated in endometriosis. To address new therapeutic options for
endometriosis, we will validate a subset of endometriosis-implicated kinases using siRNA knockdown
strategies and available small molecule inhibitors and subsequently use DNA-Encoded Chemistry Technology
(DEC-Tec) to identify novel therapeutic molecules for further chemical validation in vitro and in vivo. We
identified dozens of kinases that are statistically upregulated in the lesions of patients with ovarian
endometriosis, peritoneal endometriosis, and/or deep infiltrating endometriosis compared to control and patient
endometrium. The hypothesis for this R01 is that inhibition of one or more of these novel kinase targets will be
effective in the treatment of endometriosis. In this proposal, we outline a comprehensive approach to
functionally characterize and target kinases in primary endometriotic stromal cells and organoid cultures
derived from women. In parallel, we will utilize state-of-the-art DEC-Tec selection methods available in the
Center for Drug Discovery (CDD) at Baylor College of Medicine (BCM) to identify novel kinase inhibitors that
will then be re-synthesized without the DNA barcode and chemically optimized by our team. We currently have
a screening collection of over 6 billion DNA-encoded molecules. The overarching objective is to identify potent
and selective kinase inhibitors that can provide a foundation for new medicines to address the unmet clinical
needs of endometriosis patients. The Specific Aims are: 1) Perform target validation of overexpressed kinases;
2) Use DEC-Tec to identify novel small-molecule inhibitors of validated kinases and optimize the selectivity,
activity, and stability of high affinity kinase binders; and 3) Evaluate optimized high affinity kinase inhibitors in
vitro and in vivo. Identifying new efficacious therapies for endometriosis requires a multifaceted approach that
necessitates increased efforts to identify and screen novel targets for drug discovery. Our approach, which
combines gene expression datasets for target identification with a novel DEC-Tec drug discovery platform, will
rapidly advance key kinase targets through a well-established drug discovery pipeline. Our multidisciplinary
team is seeking to discover new chemical entities that address the non-hormonal axes of endometriosis as
stand-alone therapy or as sequential therapy during hiatus from endocrine-suppressing agents. Our DEC-Tec
platform will help us to find the first specific inhibitors of unexplored kinases (a major druggable class of
proteins) that are elevated in endometriosis to dissect these key physiological pathways and pathological
mechanisms underlying endometriosis and provide new disease-specific treatment options.

Public health relevance
PUBLIC HEALTH RELEVANCE With the decline in pharmaceutical company interest in common and morbid women’s health indications, our current proposal to identify drugs that block the functions of kinases (a druggable class of proteins in our genomes), as novel treatments for endometriosis will address an NICHD mandate of the Gynecologic Health and Disease Branch to identify and develop novel non-hormonal therapeutic agents for treatment of gynecologic pain syndromes. Our collective genetic validation, cell biology, and drug discovery experiences will bring novel drug-like inhibitors to targeted patient populations of women seeking new alternatives to control endometriosis as stand-alone therapies or as sequential treatment during the required hiatus following hormone antagonists. Our multidisciplinary team of reproductive biologists, medicinal chemists, pharmacologists, immunologists, entrepreneurs, and clinicians will work together to identify new classes of therapeutics to target unique endometriosis-relevant kinase pathways.